Administrative Core

PROJECT SUMMARY – Administrative Core
The Administrative Core is the central coordinating hub of the Duke Center for AIDS Research (CFAR), providing
leadership, support, and oversight for all CFAR-related activities, and added value through the creation of
synergistic interactions and stimulation of productive collaborations among HIV/AIDS researchers and
communities as well as throughout the inter-CFAR network. Led by Directors Drs. Georgia Tomaras, and
Susanna Naggie, the Core will provide overall financial management, maximizing the impact of CFAR funding
on the establishment of critical infrastructure in service to the community of HIV/AIDS researchers at Duke. Core
responsibilities include budgeting and allocating/re-allocating Core funds, preparing fiscal expense reports,
ensuring regulatory compliance, managing pilot grant awards, and ensuring cost efficient delivery of rigorous
research resources to our users. Administrative Core leadership will work closely with the External, Internal, and
Community Advisory Committees as well as the CFAR Executive Committee to fully implement all approved
directives, programmatic changes, and new initiatives, thus facilitating all aspects of accomplishing successful
outcomes. The Core organizes all symposia, scientific retreats, seminars, workshops, and strategic planning
sessions, and assists the Developmental Core in conducting scientific peer review of the applications received
in response to semi-annual Duke CFAR Pilot Grant RFAs. The Administrative Core promotes comprehensive
communication among the CFAR membership through the newsletter and website and leads the Community
Engagement Program. The Core will continue to serve as the main point of contact between the Duke CFAR
and the NIH CFAR Program Staff and will be responsible for organizing and submitting all forms of written and
electronic communication with the NIH, including annual Progress Reports, requests for supplemental funding,
requests for investigator status changes, rebudgeting requests, and competitive renewal applications. The
Administrative Core is firmly committed to building strong collaborative interactions among researchers on
campus; the Duke Collaborative Community Council (D3C); local, regional, and international partners; as well
as throughout the extramural HIV/AIDS research community. The strong leadership of this Core has experienced
infrastructure to promote collaboration, coordination, and innovation to accelerate advancement toward ending
the HIV epidemic and improving outcomes for people living with HIV.